Advancing Child Health Through Cellular and Molecular Biology

Project Summary / Abstract
The University of Michigan Child Health Research Career Development Award (CHRCDA) program is
designed to support the career development of junior pediatric investigators. CHRCDA scholars participate in
an intensive, mentored training program in cell and molecular biology as well as a didactic educational program
designed to ensure their continued research development. Since its launch in 1992, the Michigan CHRCDA
has contributed to the training of over 60 pediatrician-scientists, the majority of whom have obtained R-level
NIH funding for the study of childhood diseases.
The Aims of this renewal application are to: 1) Provide junior pediatric physician-scientists with the opportunity
to study basic mechanisms and the pathogenesis of diseases that impact children’s health in Michigan; 2)
Enhance the translational research training for pediatrician-scientists; and 3) Continue to recruit the most
promising junior pediatrician-scientists for training, including those from diverse backgrounds.
To achieve these Aims, the Program Director, Dr. Martin and Co-Training Directors, Drs. Hershenson and
Lumeng, will be assisted by 1) a Scientific Advisory Committee to oversee program direction and scholar
selection and evaluation; 2) an External Advisory Board to provide an independent review of the program; 3)
an Education Core to oversee scholar didactic training; and 4) a Recruitment Officer to assist in identification
and recruitment of minority candidates.
Finally, due to the urgent need to train pediatrician-scientists, the University of Michigan Medical School
Dean’s Office and the Department of Pediatrics have agreed to provide additional matching funds to complement
and extend the support to individuals received through the NIH-CHRCDA when needs are identified.

Public health relevance
Project Narrative This is a competitive renewal application for continued support of the University of Michigan Department of Pediatrics Child Health Research Career Development Award (CHRCDA) Program entitled “Advancing Child Health through Cellular and Molecular Biology.” The U-M Child Health Research Center program trains junior pediatric-scientists under the guidance of experienced biomedical scientists in scientific methods, tools and technologies that they then apply to study diseases that afflict children and young adults. The program has been highly successful in attracting accomplished physicians into careers in academic pediatrics.